Refeyn TwoMP Mass Photometer

Abstract/Project Summary
We are seeking funding to purchase a Refeyn Two-MP Mass Photometer, a cutting-edge instrument that will
revolutionize our research capabilities. This instrument enables quantitative label-free single-particle mass
measurement of biomolecules in solution, resolving a broad range of mass species (30 kDa to 5 MDa) across
various oligomeric states, quantifying protein molecular interactions, determining stoichiometry, and optimizing
conditions for functional assays and macromolecular assembly. Its integration will significantly enhance
structural, biochemical, and biological research by NIH-funded researchers at Rutgers University and Rutgers
Health. The instrument will be housed at the Mass Spectrometry core facility within the Proteomic building at
Rutgers University and Robert Wood Johnson Medical School (RWJMS). It will be the first of its kind across
Rutgers University and Rutgers Health campuses, filling a critical void in available technologies and benefiting
numerous investigators. Core users will include NIH-funded and junior investigators’ research laboratories, with
accessibility extended to other researchers. The instrument's unique ability to quantify mass with high resolution
and accuracy under native conditions with minimal sample volume and concentrations, as well as its capacity to
measure interactions in the nanomolar concentrations, make it an invaluable tool for screening samples for
structural and functional studies. Recent advancements in the microfluidics attachment to the Two-MP enable
the quantitation of weak molecular interactions at micromolar concentrations, further enhancing its utility. The
instrument’s capabilities extend beyond conventional methods, potentially replacing or complementing
techniques such as size exclusion chromatography, multiangle light scattering, electrophoretic mobility shift
assays, and protein interaction assays. We have strong institutional support from the Rutgers Health Chancellor,
RWJMS Dean, and Rutgers University to ensure support staff and space in the core facility, and service
contracts. The operation of the instrument is user-friendly, akin to the nanodrop instrument, requiring minimal
training. A support staff at the core facility will oversee routine cleaning, maintenance, and coordination of usage
and fees. A technical expert committee composed of local members with strong expertise in single-molecule
optical methods will provide consultation on experimental design and advice on data interpretation. An advisory
committee has been formed to ensure proper and efficient use of the instrument. The anticipated outcomes of
this acquisition are significant, including bolstering current NIH-funded projects and empowering junior faculty to
explore previously inaccessible research avenues. The instrument is expected to catalyze new collaborations
and discoveries across the basic, clinical, and applied research missions of Rutgers and to accelerate biomedical
discoveries widely.

Public health relevance
Project Narrative Quantifying biomolecular interactions is crucial for understanding cellular processes. Acquisition of the Refeyn Mass Photometer will enable rapid and quantitative characterization of biomolecular interactions in large complexes, empowering NIH-funded researchers on the Rutgers University campuses. The instrument will play a critical role in promoting new discoveries in biomedical related research projects aiming to understand structure and function of biological complexes.